Discovery of Chemical Probes of SAMHD1 for Modulation of Cancer Therapy and the Immune System

The enzyme Sterile Alpha Motif domain-Histidine aspartate Domain-containing protein 1 (SAMHD1) is a
multifunctional enzyme possessing both dNTP triphosphohydrolase (dNTPase) and DNA damage repair (DDR)
activities. It is becoming increasingly clear that the enzyme lies at a critical nexus between dNTP pool
regulation and cellular nucleic acid homeostasis. Of significance to cancer therapy is its highly promiscuous
dNTPase activity, which is the primary mechanism of clinical resistance to the nucleoside anticancer drugs
cytarabine and decitabine triphosphate. A phosphorylated form of SAMHD1 (pSAMHD1) binds to single-
stranded DNA in vitro and at stalled replication forks (RF). In the absence of functional pSAMHD1, tumor cells
with intrinsic replication stress spill fork-associated ssDNA into the cytoplasm, triggering the cGAS/STING
nucleic acid-sensing pathways, thereby inducing interferon-stimulated genes. This newly discovered function
raises the prospect that inhibition of SAMHD1 could enhance anti-tumor immune responses, particularly in the
context of immune checkpoint inhibitors. We intend to discover small molecule inhibitors and activators of
SAMDH1 activities to serve as research tools that will facilitate understanding of the role of SAMHD1 in
nucleoside drug resistance and immune sensing pathways. This proposal is unique because we utilize both
high-throughput screening (HTS) and fragment tethering approaches. In Aim 1 we will use a high-throughput
dNTPase assay (Z´ = 0.87) to screen a custom-designed 100,000-member library available at the Hopkins
ChemCore screening facility. Rapid orthogonal secondary screens have also been developed and hits will be
validated and characterized for their MOA using a panel of in vitro assays and cell-based counter screens.
These probes are expected to target a diversity of sites on SAMHD1 (activator sites, the catalytic site, or sub-
unit interfaces). In Aim 2, our fragment tethering approach is supported by the structure and allosteric
activation mechanism of tetrameric SAMHD1: the enzyme has closely adjacent binding pockets for two
essential nucleotide activators (A1 and A2), which must be occupied to drive formation of the active tetramer
from monomers. Tethered ligands that target the A1 and A2 sites have the highest potential to facilitate
discovery of both inhibitors and activators of SAMHD1 because co-occupancy of these sites with various
nucleotides is already known to give rise to either outcome depending on the ligand structure. We have already
identified appropriate nucleoside and small molecule fragments for tethering. In Aim 3, a panel of cellular
assays will be used to elucidate the effects of validated probes on (i) cellular dNTP pool levels, (ii) RF restart,
(iii) DSB repair via homologous recombination, (iv) increasing the potency of anticancer nucleoside-based
drugs in cell culture, and (v) prevention of nucleoside drug resistance. The resulting molecules should provide
a diverse set of chemical probes that facilitate our understanding of SAMHD1 biology and how its dNTPase
and immune suppression functions might enhance tumor death.

Public health relevance
This application proposes a multifaceted approach to discover chemical probes of the enzyme SAMHD1. Such probes will be valuable for manipulating the dNTPase and DNA repair functions of this enzyme that are involved in carcinogenesis, antimetabolite drug therapy, autoimmunity disease, viral infections, and expression of endogenous retroelements.